Ultrasound-mediated thrombolysis for MVO and PAO treatment.

ABSTRACT
Encouraging results have been obtained with microbubble (MB) enhanced sonothrombolysis (SL) to treat
vascular occlusions in acute ST elevation MI (STEMI), peripheral arterial occlusions (PAO) and ischemic stroke.
However, there is no approved MB for these indications. Thrombi are porous structures composed variably of
RBC’s, fibrin and platelets. MB are micron sized structures and probably too large to effectively permeate
thrombi. Efforts to remove occlusive thrombi via thrombectomy, mechanical disruption, and/or biochemical
dissolution have demonstrated efficacy; however, these are time consuming, show mixed results in improving
clinical outcomes, and are accompanied by substantial risk of hemorrhagic complications. Efforts to enhance the
safety and efficacy of thrombus removal have high potential clinical impact. Ultrasound (US) has been shown
to disrupt thrombi and MB can locally amplify and accelerate US-enhanced thrombolysis at a lower energy
level. A caveat to the use of MB stems from their size (1-3 microns), which may limit their access to the interior
of the microthrombi responsible for MVO and PAO. Smaller acoustically active materials, including phase change
nanodroplets (ND, ~100-200 nm), should more easily penetrate thrombus to increase sonothrombolytic
efficiency and clinical efficacy. Microvascular Therapeutics (MVT) has developed a safe and more stable lipid-
based MB (MVT-100) less likely to induce anaphylactoid reactions as compared to Definity® and is developing
MVT-100 via the 505(b)(2) pathway. Moreover, MVT has subsequently made ND from MVT-100 (Patent, US
9,427,410B2; herein referred as MVT-101) and conjugated ND with a peptide ligand with high affinity for fibrin
(FTND). Electron microscopy of fibrin clots shows that FTND permeate clot > non-targeted ND >> FTMB>MB.
Preliminary studies performed in our laboratory as well as by our collaborators at the University of Pittsburgh
Center for Ultrasound Molecular Imaging and Therapeutics in an in vitro model of MVO show that fibrin micro-
clots are disrupted by US with ND >> MB. Finally, our international co-Investigator was able to show in a recent
clinical study of SL in acute PAO that Definity® plus US shortened the time to reperfusion compared to standard
lytic therapy along. In this R33 Catalyze Program, our combined groups propose to formulate and characterize
fibrin targeted MB (FTMB) and ND (FTND) and evaluate their effectiveness in vivo in disrupting the microvascular
thrombi in biologically relevant models reflective of MVO during acute myocardial infarction and PAO. After
production of bioconjugate and FTND/FTMB, we will evaluate their binding to the fibrin target. We hypothesize
that FTND will improve fibrin clot detection and achieve superior dissolution of thrombi upon US activation as
compared to MB and FTMB. The overall goal of this program is to obtain in vivo results in both animal models
for the usage of FTNDs and perform feasibility studies which will, if successful, support further preclinical
development and IND-enabling studies of ND for either PAO or MVO therapeutic indication.

Public health relevance
PROJECT NARRATIVE Encouraging results have been obtained with microbubble (MB) enhanced sonothrombolysis to treat vascular occlusions (MVO) in acute ST elevation MI, peripheral arterial occlusions (PAO) and ischemic stroke. However, there is no approved MB for these indications. Microvascular Therapeutics has developed novel Ultrasound- Stimulated Phase-Change Contrast Agents for sonothrombolysis. The overall goal of this CATALYZE R33 program is to obtain in vivo results for the usage of Fibrin Targeted Nanodroplets in models of PAO and MVO and to perform feasibility studies which will, if successful, support further preclinical development and IND- enabling studies of FTND for either PAO or MVO therapeutic indication.